LUTEINIZING HORMONE ACTIONS IN POLYCYSTIC OVARY SYNDROME

This study tests the primary hypothesis that women with polycystic ovarian (PCO) syndrome exhibit increased ovarian sensitivity to pituitary LH's stimulation of androgen secretion; secondarily, we will assess the potentiating role of chronic hyperinsulinemia and/or LH hypersecretion on androgen excess.